U-RISE at Florida Atlantic University

The central goal of this proposed program is to expand the pool of students from Florida Atlantic University (FAU) who enter PhD, MD/PhD, or related programs in Biomedical Science. This supplement seeks to build on our current curriculum and leverage unique research strengths at FAU by developing a year-long Classroom Undergraduate Research Experience (CURE) that exposes students to mentored research in their sophomore year. The course will allow students to develop a gene-editing mediated high-througput screen in fish, followed by developmental and behavioral genotyping. Each trainee will be paired with a graduate mentor, and gain experience in scientific methodology, cell biology, genomics, and molecular biology, and scientific communications. Key deliverables include two manuscripts, one describing the methodology and assessment of the CURE, as well as a second group manuscript authored by the students describing research outcomes.

Public health relevance
Narrative This U-RISE seeks to develop an immersive research intensive class for first year U-RISE students, and other URM students interested in pursuing biomedical research at FAU. The course will engage students in mentored research where they develop their own gene-editing based screen in fish, resulting in a group publication and preparing students for research in their host laboratories.